Digital Twin for Radiation-Induced Immune Suppression Estimation and Reduction

This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-CA-24-015.
Radiation-induced lymphopenia (RIL) is a common immunotoxicity associated with radiotherapy (RT) or
chemoradiotherapy. Severe RIL (sRIL) has been shown to significantly impact patient survival and other outcomes. Most
recently, it has become evident that sRIL can also diminish the effectiveness of immunotherapy significantly, when used
in conjunction with RT. We have demonstrated that proton therapy, because of its smaller dose bath, can lead to
significant sparing of the immune system. Project 2 of the parent NCI P01 is exploring the dosimetric and clinical
determinants of RIL and correlation of RIL with patient outcomes, developing personalized machine learning RIL
prediction models, and investigating strategies to mitigate RIL for cancers of the esophagus, lung, brain, liver, and
pancreas. Our preliminary studies have suggested that the most effective RIL mitigation approach is the use of intensity-
modulated proton therapy (IMPT) optimized based on personalized RIL models. The purpose of the research proposed
in this supplement application is to develop a DTRO framework with the following objectives: (1) Incorporate the
response deduced from lymphocyte depletion rate after initial treatment fractions (up to 5) to dynamically boost the RIL
prediction accuracy for a given patient and adapt (reoptimize) the IMPT plan to minimize immune toxicity. (2) Validate
and dynamically update the personalized RIL prediction models based on continuous feedback from actual responses.
(3) Quantify uncertainties in model predictions and consider them when making treatment decisions. Specific Aims
include the following: (1) Deploy and evaluate a bi-directional feedback DTRO system between the physical and virtual
components of the Phase I clinical trial planned in Project 2 of the parent grant. (2) Amend the Phase I trial schema to
form a feedback loop to dynamically update the personalized models. (3) Conduct uncertainty quantification analyses to
establish confidence intervals around the model predictions and incorporate uncertainty estimates in decisions before
treatment start and again after adaptation and reoptimization based on the response to initial fractions. The proposed
trial will be implemented for a cohort of esophagus patients to investigate the potential of DTROs in general and the
clinical effectiveness of the RIL mitigation approach. Our research will utilize multiscale data, including patient clinical
characteristics, dosimetric parameters, adjuvant and concurrent chemotherapy details, and immune system biomarkers
for a large cohort of esophagus patients previously treated at our institution. Similar data will be collected for each
patient enrolled and treated prospectively in the DTRO-based trial. This research will be a collaborative effort among
radiation oncologists, radiation physicists and data scientists. Our ultimate objective is to gain a comprehensive
understanding of factors contributing to RIL incidence and severity. We will incorporate this knowledge to enhance the
accuracy of prediction models and apply them to optimize treatment plans and clinical decision-making. We anticipate
that this DTRO will lead to further improvements in outcomes beyond what is possible with the research proposed in the
parent P01. Concepts and models developed as part of this research will be made available for broader use.

Public health relevance
Narrative Radiation therapy (RT), a key pillar of cancer management, causes a common, yet often ignored, side effect – immune system suppression (i. e., radiation-induced lymphopenia [RIL]). Severe RIL has been linked to poor cancer treatment outcomes, presumably due to the reduced tumor surveillance by the immune system, thereby increasing disease recurrence and distant metastasis after RT. We propose approaches, strengthened greatly by the Digital Twins for Radiation Oncology supplement, to identify clinical and dosimetric factors that predict the risk and severity of RIL and understand the impact of RIL on the immune diversity and profile as it affects clinical outcomes; to develop models that can accurately predict the risk of RIL line clinical factors; and to use such models in the optimization of radiation dose distributions to mitigate RIL and its impact on outcomes.